Development of NH101: A Simple and Efficient Outpatient Dry Powder Amphotericin B-DryNeb(dry powder nebulizer) for Treatment of Susceptible and Multidrug Resistant Aspergillus/ Fungal Infections

Project Summary
The overall objective of this project is to build on the successes of our Phase I SBIR studies to
progress NH101: a pure (neat) dry powder of amphotericin B (AMB) combined with the DryNeb™,
a novel dry powder nebulizer to “clinic ready” status. The results of this program will enable a
Phase I clinical study (AUS), engagement with the FDA on the NH101 505(b)(2) regulatory
approval pathway, and ultimately, an Investigational New Drug (IND) application and Phase II
clinical proof of concept (POC) efficacy testing in Allergic Bronchopulmonary Aspergillosis (ABPA).
NH101 (AMB-DryNeb™) satisfies multiple unmet medical needs by targeting common and
triazole (antifungal classes, e.g., itraconazole) multidrug resistant (MDR) strains of aspergillus at
the site of lung infection. NH101 will initially focus on cystic fibrosis (CF) and asthma-associated
ABPA, a rare, orphan and severe disease of unmet medical need commonly associated with an
estimated 2.5% of asthmatics (~5 million) and 15% (~20,000) of CF patients. This project will
achieve three primary objectives: 1) refine, test, and produce the DryNeb™ to clinical-grade scale,
2) scale up and formulate AMB at Kg scale, and 3) perform a first in human-enabling repeat dose
GLP toxicology study.

Public health relevance
Project Narrative Multidrug Resistant (MDR) pulmonary fungal infections pose an important threat to public health and increase morbidity and mortality in asthmatics and cystic fibrosis patients. If successfully developed, the proposed NHT101 (dry powder nebulizer [DryNeb]-amphotericin B) product will overcome major limitations of existing antifungal therapies to treat lung diseases in which MDR is emerging.